Self-Administered Acupressure for Veterans with Chronic Back Pain: A Multisite Evaluation of Effectiveness and Implementation

Background: It is estimated that about half of the 9 million Veterans who receive care at Veterans Health
Administration (VHA) have chronic pain, of which chronic low back pain (CLBP) is a major type. Veterans with
CLBP are high healthcare utilizers and are experiencing a dramatic shift in care – from a medical approach
that relied on medications like opioids for pain management to a biopsychosocial approach in which evidence -
based, lower risk non-pharmacological options are favored. Non-pharmacological interventions, which include
complementary and integrative health (CIH) treatments, are now a first line of care. Consequently, Veterans
need to be able to access these treatments, but they are complex to deliver and difficult to provide in real-world
settings. Thus, non-pharmacological treatments for CLBP need to not only be effective, but also low cost,
easy-to-administer, accessible, and acceptable to Veterans and to their providers.
Significance: Our long-term goal is to improve chronic pain management for Veterans with CLBP by
integrating an effective self-administered acupressure intervention into VHA using current structures that
support Veteran-centered care. The proposed project is a crucial first step. It directly addresses priorities from
VA, HSR&D, and CARA legislation that seek to provide greater access to non-opioid options for chronic pain,
including CIH treatments like acupressure.
Innovation and Impact: This project leverages the unique infrastructure within VHA to test and deliver
interventions that could have system-wide uptake. Self-administered acupressure is an ideal intervention to
test using the existing VHA support structure for CIH treatments, the Whole Health System. Self-administered
acupressure is a promising candidate for uptake at VHA given its low risk and ability to be performed at home
at any time. In addition to providing evidence that can inform VA clinical practice guidelines for low back pain
on effectiveness of self-administered acupressure for CLBP, this project will also inform on how to begin to
implement this treatment at VHA, which would support the recent CIH Directive that outlines processes for how
to integrate CIH treatments for Veterans.
Specific Aims: Aim 1: Determine effectiveness of a 6-week self-administered acupressure protocol on pain
interference, disability, fatigue, and sleep post intervention, and [sustained effects at 10 weeks] and 2)
Evaluate supports and barriers for implementation of self -administered acupressure to Veterans with CLBP.
Methodology: A Type 1 effectiveness-implementation hybrid study will be conducted at three VA sites: Ann
Arbor VA Medical Center, Toledo Community-Based Outpatient Clinic, and Flint Community-Based Outpatient
Clinic. There will be 300 Veterans recruited from providers at these sites and through classes offered through
the Whole Health System, an initiative designed to teach Veterans how to self-manage aspects of their health.
Participants who are randomized into the stimulating acupressure arm will be compared to participants
randomized into a wait list control group and implementation factors will be measured quantitatively and
qualitatively. This work is guided by dissemination frameworks, engaging stakeholders, measuring fidelity,
considering site characteristics, and assessing facilitators and barriers to implementation.
Next Steps/Implementation: This study contributes to the knowledge base of self -administered acupressure
as a treatment for symptoms in CLBP, extending the state of the research beyond efficacy studies. It fills a gap
in knowledge about effectiveness and how to best implement self-administered acupressure. This project will
provide critical information that can increase the ability to access a patient-preferred, non-opioid pain
treatment. If self-administered acupressure is effective, next steps would be to test implementation across
several VA sites in different regions and more comprehensively examine facilitators and barriers considering
geographical and cultural differences in Veterans across the country.

Public health relevance
The large number of Veterans with chronic low back pain who seek care at the Veterans Health Administration (VHA) are being asked to try non-drug options before higher-risk pain medications. Although there are effective non-drug options, including complementary and integrative health treatments, they can be challenging to access. This research will examine self -administered acupressure for pain relief for Veterans with chronic low back pain. It is a low-risk treatment shown to be effective for people with other pain conditions and can be done virtually anywhere with an app for guidance. This study will engage Veterans an d other stakeholders to help [determine strategies to best integrate acupressure into VHA if effective and offer the app through a Whole Health class at three VA sites and virtually]. This study will contribute to evidence for self-administered acupressure as a treatment for chronic low back pain and begin to examine how it can be sustained system- wide using established resources.